Mechanisms of transgenerational epigenetic alterations induced by polybrominated biphenyls

PROJECT SUMMARY/ABSTRACT
Knowing how environmentally-induced epigenetic alterations are established in the mammalian germline,
transgenerationally inherited, and contribute to disease in the adult, can lead to a more complete understanding
of pathophysiology as well as novel preventive care opportunities. However, the mechanisms underlying the
transgenerational inheritance of epiphenotypes remain perplexing due to the extensive epigenetic remodeling
that happens in the germline during germ cell development and after fertilization. Work from the Corces lab
suggests that aberrant transcription factor (TFs) occupancy due to environmental perturbations during primordial
germ cell (PGC) development shields regions from DNA-methylation remodeling and results in lasting changes
in chromatin accessibility. Understanding the protein makeup, genomic distribution, and fate of environmentally
induced TF binding sites from the gametes to the post-implantation embryo is essential to understand how
germline epimutations can withstand epigenetic remodeling, and how these alterations can influence the health
of later generations. To address these issues, we propose to examine the transgenerational effects of
polybrominated biphenyls (PBBs). Rural populations in Michigan were highly exposed to PBBs in contaminated
livestock in the 1970s, resulting in numerous adverse health outcomes in individuals exposed in utero, including
earlier puberty and other reproductive alterations by mechanisms that remain unknown. Whether this mass
exposure could have transgenerational effects is also unknown. My preliminary mouse studies show that PBB
exposure during PGC development leads to differentially accessible sites in sperm chromatin containing binding
sites for the androgen receptor (Ar) that persist transgenerationally. This mouse exposure results in similar
maternal adipose PBB levels as directly exposed Michigan residents, and leads to early puberty in female F1
mouse offspring, as observed in daughters of directly exposed mothers from the Michigan PBB registry.
Importantly, early puberty is also observed in the unexposed F3 generation in mice. The goal of the proposed
project is to use this mouse model reflecting the Michigan PBB exposure to increase our basic understanding of
the transmission of epimutations with direct relevance to the exposed Michigan population. Aim 1 will test the
hypothesis that transgenerationally persistent Ar footprints in sperm chromatin are hypomethylated, bound by
Ar, and are flanked by nucleosomes possessing histone variants and modifications indicative of enhancers.
Further, this aim will test the hypothesis that ancestral PBB exposure also results in differential Ar footprints in
oocytes that overlap with those observed in sperm. Aim 2 will test the hypothesis that TF sites induced by PBB
exposure are transmitted from the gametes to the embryo after fertilization. These experiments will generate
highly significant results that will fill a critical gap in our understanding of the mechanisms governing
transgenerational phenomena in mammals that will be directly applicable to the understanding of the health
problems affecting thousands of exposed Michigan residents and their descendants.

Public health relevance
PROJECT NARRATIVE Increasing evidence from animal studies and humans suggests that exposures to environmental insults during fetal development can promote adverse health outcomes that persist transgenerationally by mechanisms that remain unknown. Mouse prenatal exposure to polybrominated biphenyls (PBBs), a flame retardant that people in rural Michigan were highly exposed to in the 1970s, leads to reproductive phenotypes in mouse descendants that mirror those observed in affected Michigan populations, and results in transgenerationally persistent newly accessible transcription factor (TF) footprints in the mouse sperm chromatin. The proposed project will assess the molecular makeup of transgenerationally persistent PBB-induced TF footprints in sperm, the genomic distribution of these sites in oocytes, and the fate of these epimutations from the gametes to the E6.5 postimplantation embryo, when the germline is specified.